Large Animal Core

Core B Summary
The Large Animal Core provides the facilities, management and technical expertise needed to supply miniature
swine and baboons and tissue samples for all projects of the proposed program as well as expert veterinary
care, immunological reagents, and microbiologic diagnostic assays and support. Clinical samples are distributed
to maximize utilization of each animal for studies of clinically relevant regimens for xenotransplantation. The
success of each component of this program is dependent on the quality, predictability, and accessibility of the
animals, microbiologic support, and antibodies provided by this Core. Animal care is reviewed weekly at
meetings of the principal investigators and the veterinary staff. The Aims of the Large Animal Core include: Aim
1: Purchase and maintenance of non-human primates; Aim 2: Oversee and coordinate the production and
maintenance of an SPF facility of MHC inbred miniature swine including genetically engineered knock-out and
transgenic swine, derived by Caesarian section when assurance of pCMV-free status is required for use as
xenograft donors; Aim 3: Carry out genetic and phenotypic screening, quality control, and tracking of miniature
swine in Aim 2; Aim 4: In conjunction with Core C, develop and maintain new genetically engineered swine
designed to facilitate tolerance induction; Aim 5: Develop and utilize protocols to synchronize estrus and time
of breeding, in order to increase farrowing percentage and better control and predict production levels; Aim 6:
Provide diagnostic and management support related to infectious diseases, including prophylaxis and care
paradigms for the care of immunosuppressed xenograft recipients and support of ongoing studies by routine
assessment of swine and baboon recipients for pCMV, bCMV, PERV and other pathogens.